HPF-X: High-pressure freezing with buffer exchange

PROJECT SUMMARY ABSTRACT
Ligand-triggered events are central to many processes in neuroscience, endocrinology, virology, immunology,
and pharmacology. However, molecular and ultrastructural changes that follow the stimulus are difficult to
visualize because they involve rapid nanoscale motions and modifications of proteins and membranes. State-of-
the-art techniques are insufficient to capture these spatiotemporal changes. For example, live fluorescence
imaging is limited by the spatial resolution (diffraction-limit) and labeling constraints (no antibody access or
washing in live cells), while nanoscale imaging methods either lack temporal resolution to capture fast dynamics
(e.g., super-resolution optical microscopy) or are incompatible with live-cell imaging altogether (e.g., standard or
cryo-electron microscopy; expansion microscopy). Given these limitations, time-resolved cryo-vitrification
methods are ideal for capturing cellular processes after a defined wait time post-stimulation by freezing samples
in the state of amorphous ice prior to imaging. High-pressure freezing (HPF) is often used for this purpose
because of its relaxed sample thickness constraints (<300 µm) as compared to cryo-plunging at atmospheric
pressure (<10 µm). However, an HPF device compatible with time-resolved buffer exchange does not currently
exist. To this end, we will develop HPF-X – an HPF device with a capability for time-resolved buffer exchange
preceding cryo-vitrification. Buffer exchange will allow stimulating the sample with various biological and
pharmacological agents including ions, small molecules, peptides and proteins (e.g., hormones, cytokines,
antibodies, and nanobodies), and even viruses and cells. Thus, HPF-X will allow cryo-vitrifying cells, tissue
samples, or entire small organisms at a series of time points following stimulation with ligands for subsequent
interrogation with nanoscale imaging techniques such as electron microscopy and super-resolution optical
microscopy. This approach will allow capturing ligand-triggered cellular processes with nanoscale spatial
resolution and temporal resolution of <50 ms. Biological applications of this technique include nanoscale imaging
of protein-protein interactions, post-translational modifications, and protein-membrane dynamics. Although a
fundamentally new HPF instrument design is required to allow buffer exchange, our extensive preliminary data
confirms feasibility. In Aim 1, we will develop a high-pressure chamber compatible with buffer exchange and
cryo-vitrification and characterize its performance. In Aim 2, we will develop a method for time-resolved cryo-
cooling and validate the system using gold-standard biological samples. Development of HPF-X is an emergent
technical opportunity given the advent of nanoscale bioimaging. Importantly, this work goes beyond the current
method development regime in cryo-vitrification field because all available HPF devices are commercial. Our
custom-built HPF-X instrument will allow full control, versatility, and ease of adoption and modification by other
researchers based on their project needs, which cannot be achieved with off-the-shelf HPF instruments.

Public health relevance
PROJECT NARRATIVE We propose to develop a high-pressure freezing instrument with the buffer exchange capability (HPF-X) for time- resolved cryo-vitrification of cells and tissues with a goal to study ligand-induced biological processes at high spatiotemporal resolution. Biomedical applications of this technique include nanoscale imaging of rapid protein- protein interactions (e.g., receptor-effector coupling), post-translational modifications (e.g., phosphorylation), and protein-membrane dynamics (e.g., exo- and endocytosis). Our custom-built high-pressure freezer with the buffer exchange capability will allow full control, versatility, and potential for adoption and modification by other researchers based on their project needs, which cannot be achieved with off-the-shelf HPF instruments.